Therapeutic strategies for treatment of giant congenital melanocytic nevi

Abstract
Congenital Melanocytic Nevi (CMN) can reach giant sizes, transform to childhood melanoma, and thus trigger
pre-emptive surgery inducing profound morbidity. In the prior funding period, we constructed four CMN models
to test regression-inducing treatments aimed at avoiding surgery. Three are genetically engineered mice driven
by the (floxed)NRASQ61R oncogene, responsible for most human CMN, with melanocyte-targeting via tamoxifen-
inducible or constitutive expression from Tyr or Dct promoters (varied strengths). The fourth model is xenografted
resected human CMNs on immunodeficient mice. Several models displayed melanoma transformation after long
latency. Inducible NRASQ61R clarified the kinetics of proliferative vs senescent nevus phases and verified
regressive treatments to succeed in either phase. Tyr-Cre;NRASQ61R exhibited severe human-like CNS and skin
lesions whereas the weaker Dct-Cre induced a more typical skin-restricted giant nevi for which inhibitors of MEK,
PI3K, or cKIT induced incomplete (~80%) regressions and combinations fully depleted visual nevocytes. Topical
treatment with the proinflammatory hapten Squaric Acid Dibutyl Ester (SADBE) induced complete visual CMN
regression after 3 doses. This regimen also fully prevented murine melanoma transformation, within all treated
nevus skin. We found that topical SADBE requires macrophages (not B, T, or NK cells), so it could be tested in
human CMN xenografted onto SHO mice (which lack adaptive immunity but retain macrophages). SADBE
recruited murine macrophages into the human xenografts and regressed ~90% of the human nevocytes. Since
SADBE is already used elsewhere in dermatology, and has been reported to induce “depigmentation,” we plan
to test it clinically. However, since clinical trials with efficacy endpoints are not supported in R01s from NIAMS,
we are seeking separate funding to support this clinical trial that already received FDA/IND and IRB approvals.
While we are excited by the models and strategies uncovered during this funding period, we believe it is crucial
to build on this progress to increase the likelihood of achieving real therapeutic breakthrough for this devastating
children’s disease. Accordingly Aims 1-3 use our models to boldly seek further enhanced efficacy and minimized
toxicity of treatments: Aim 1 deeply and systematically develops kinase inhibitor combinations. It also tests MEK
inhibitors (MEKi) with SADBE, as both exhibit individual efficacy and MEKi was recently shown to promote M1-
like (pro-inflammatory) over M2-like macrophage differentiation, a mechanistic feature that may enhance
SADBE’s efficacy. Aim 2 seeks localized T cell adaptive immunity recruitment, to complement SADBE’s
macrophage induction. We have shown anti-PD1 triggers recruitment of melanocyte (gp100) targeted T-cells
when combined with topical SADBE. We will also combine fractional laser treatment plus anti-PD1 which, as we
recently published, also triggers local recruitment of melanocyte-targeted T-cells. Aim 3 systematically uses our
models to test varied dose/schedules of anti-inflammatory approaches that are commonly used in infants, to
optimize SADBE’s nevus regression efficacy while minimizing cutaneous toxicity and inflammatory symptoms.

Public health relevance
Project narrative: Giant congenital melanocytic nevi are very large birthmarks which produce increased probability of malignant melanoma formation, and therefore are commonly surgically removed in childhood, leaving major permanent morbidity over much of the body surface. In the current funding period, we generated four mouse models which allowed us to identify drug treatments that kill the nevus cells, including one that also displayed protection against melanoma. We propose studies to build on this progress, aiming to obtain treatment for this devastating childhood condition that can avoid a need for highly morbid permanently debilitating surgeries.